Administrative Core

ADMINISTRATIVE CORE ABSTRACT
The HU RCMI involves a collection of Cores and research projects with differing objectives and needs that are
all focused on the advancement of the understanding and resolution of difficult issues surrounding minority
health and health disparities. It is the responsibility of the Administrative Core to recognize the support needs
of each of these components and develop plans and strategies to meet their distinct needs. In addition to
providing general administrative support directly for each program component, this core will provide
professional development trainings to HU investigators as well as deliver ongoing evaluation services on behalf
of the overall program and its various components. In order to achieve all the duties of the required of the
Administrative Core, a dedicated and committed staff with clear and defined roles and responsibilities are
essential. This staff consists of the Principal Investigator, Administrative Director, Program Manager,
Administrative Coordinator, Professional Development Coordinator, and External Evaluator. The
Administrative Core will implement a strong and equitable management and governance plan that is inclusive
of all HU RCMI stakeholders. The central pillars of this plan are the HU RCMI Steering Committee and the
Advisory Committee. The specific aims of the Admin Core are as follows: 1) provide administrative, logistical,
and coordination support for all program components, including the RCMI-supported research projects, 2)
provide professional development training activities for the Investigator Development Core awardees and to
the greater HU investigator community, 3) provide an evaluative assessment of each Core component of the
HU RCMI, the RCMI-supported research projects, as well as the overall HU RCMI program, to determine HU
RCMI’s overall impact on biomedical and clinical research at HU. Finally, the HU RCMI will have institutional
support from Howard University for the maintenance of program activities at the level of 20% of annual
program-generated F & A costs.